Investigating the relationship between age-related skeletal muscle insulin resistance and cognitive impairment

Abstract
In this ADRD supplement, we propose to expand the scope of work in Aim 1 of our NIH/NIA 1R15AG073922
(expires 2024). The scope of work in the funded R15 centers on understanding the cellular mechanisms in
skeletal muscle that contribute to age-related insulin resistance. Specifically, Aim 1 of the parent grant examines
mechanisms contributing to age-related skeletal muscle insulin resistance at the level of AS160 phosphorylation,
the most distally located protein in the insulin signaling cascade. Alzheimer’s disease and Type 2 diabetes are
currently ranked amongst the top 7 causes of death for individuals over the age of 65 years (CDC). Insulin
resistance has been well-recognized as the primary contributor for the development of type 2 diabetes. Similarly,
mild cognitive impairment is often a precursor for the development of Alzheimer’s disease. While each condition
has been traditionally thought of as the early pathogenesis for their respective disease, growing evidence
suggests that insulin resistance plays a critical role in the development of cognitive impairments leading to
Alzheimer’s disease. Insulin resistance has been reported in older adults with mild cognitive impairment and
Alzheimer’s disease. Additionally, insulin resistance has been associated with brain atrophy in regions affected
by early Alzheimer’s disease. Skeletal muscle is the main target of insulin-mediated glucose uptake; therefore,
it is the ideal tissue to investigate the relationships between age-related skeletal muscle insulin resistance and
cognitive impairment. Unfortunately, no known research has investigated the relationship between the skeletal
muscle mechanisms contributing to age-related insulin resistance (parent grant) and cognitive impairment;
therefore, we propose two proof-of principal specific aims to examine the nexus between these critically
important conditions negatively impacting the aging process. Aim 1 will determine if impaired skeletal muscle
insulin-stimulated AS160 phosphorylation is related to reduced cognitive domains of learning/memory,
psychomotor processing speed, and executive functioning in older adults, and whether older adults with MCI will
have lower AS160 phosphorylation compared to older adults that are cognitively normal. Aim 2 will determine if
impaired skeletal muscle insulin-stimulation of AS160 phosphorylation is associated with biomarkers of cognitive
impairment (p-181 tau, neurofilament light chain, beta-amyloid-42, acylcarnitines, and the apoE4 allele). To
accomplish these aims we will add a cohort of older adults with MCI (n=12) to the proposed scope of work in the
parent grant and add cognitive function testing and genetic apoE4 allele testing to all aged adults enrolled during
the 1-year supplement (n=12 aged MCI and n=12 aged cognitively healthy from parent grant). Further, all stored
blood (n=12 aged MCI from supplement, n=12 aged and n=12 young cognitively healthy from parent grant) will
be tested for biomarkers of cognitive impairment. At the completion of this supplement, we expect to have
provided proof-of principal demonstrating a link between impaired skeletal muscle glucose metabolism,
specifically impaired insulin-stimulated AS160 phosphorylation and cognitive impairments. Additionally, this
supplement will provide an opportunity for students to be exposed to translational and multidisciplinary research,
while learning about the age-related health concerns.

Public health relevance
Project Narrative The proposed research in this ADRD supplement will advance our understanding regarding the relationship between age-related insulin resistance and cognitive impairment. It will provide novel insight into the relationship between skeletal muscle metabolism and cognitive performance, and examine the use of easy access biomarkers to provide knowledge on the health of skeletal muscle and mind in older adults.